Engineered biomaterials for promoting lymphatic regeneration in lymphedema

PROJECT SUMMARY
Lymphedema results from the underdevelopment or destruction of the lymphatic system, causing fluid and fat
accumulation in the affected limb, immune imbalance, repetitive infections, and limb deformity. This condition
severely compromises the patient's quality of life, functionality, and aesthetics. Over 35 million Americans and
150 million people worldwide suffer from lymphedema, making it a significant global healthcare issue.
Vascularized lymph node transfer (VLNT) has emerged as a therapeutic treatment for patients, although
currently less than half of patients treated with VLNT will have a therapeutically beneficial response to treatment.
The primary goal of this research initiative is to integrate advanced biomaterials and targeted delivery of lipid
nanoparticles into current lymphedema surgical procedures with the aim of augmenting lymphangiogenesis for
enhanced lymphedema treatment. Various formulations of lymphangiogenic hydrogels, conjugated with either
wild-type or mutant Vascular Endothelial Growth Factor-C (VEGF-C) targeting Vascular Endothelial Growth
Factor Receptor-3 (VEGFR3), along with a specialized lymphatic-targeting lipid nanoparticle for delivery of
VEGF-C mRNA, will be evaluated for their synergistic effects in ameliorating the consequences of vascularized
lymph node transfer (VLNT) and mitigating lymphedema following lymph node dissection and irradiation. A rat
hindlimb model of lymphedema induced by inguinal lymph node dissection and irradiation will facilitate this
investigation due to its superior physiological relevance and disease persistence compared to mouse models of
secondary lymphedema. Monitoring of limb volumetry, lymphatic function, and drug biodistribution throughout
disease progression and therapeutic intervention will be conducted using techniques including iPhone volumetry,
dual-wavelength near-infrared imaging, and isolated vessel biomechanics testing. This comprehensive study is
structured around three specific aims: Aim 1 will evaluate lymphangiogenic hydrogels and their capacity to induce
lymphangiogenesis and facilitate engraftment of transplanted lymph nodes into the host lymphatic vasculature.
Aim 2 will assess the efficacy of the controlled release of vascular growth factors from the hydrogel to enhance
its integration into the host lymphatic vasculature and restore lymphatic function without the need for a
transplanted lymph node. Aim 3 will investigate the combined approach of mRNA delivery utilizing Lymphatic
Endothelial Cell-targeting Lipid Nanoparticles (LECs-LNPs) and hydrogel to bolster lymphangiogenesis further,
thereby augmenting the effectiveness of vascularized lymph node transfer and preventing lymphedema post-
lymph node dissection and irradiation.

Public health relevance
PROJECT NARRATIVE This proposed study aims to leverage biomaterial and drug delivery methodologies to achieve two primary objectives: firstly, to augment lymphatic regeneration by integrating hydrogels that promote lymphatic growth with vascularized lymph node transfer (VLNT), and secondly, to encourage lymphatic vessel expansion at site distal to the original lymphatic injury using drug delivery to the lymphatics. This will be accomplished through advanced biomaterial implantation and targeted mRNA delivery to stimulate lymphatic growth factor production. The outcomes of this research endeavor are anticipated to pioneer a novel therapeutic approach for improving the efficacy of VLNT as a lymphedema treatment.